Role of the NFkB signaling network in generating memory B cell and long-lived plasma cell

Abstract
The generation of long-lasting humoral immunity is the purpose of almost all vaccines. Long-lasting humoral
immunity is mediated through antibodies produced by long-lived plasma cells (LLPCs) and memory B cells
(MBCs) that respond rapidly to pathogens. Despite the outstanding success of vaccinations overall, many clinical
and experimental vaccines fail to induce long-lasting humoral immunity. One key example is the influenza
vaccine, which requires administration every year.
Upon encountering a foreign antigen, antigen-specific B cells proliferate and differentiate into germinal center
(GC) B cells and subsequently generate LLPCs and MBCs. B cell receptor and CD40 receptor signaling result
in the activation of NFkB in GC B cells. It is well established that transcription factors NFkB cRel and RelA are
critical for physiological B cell responses and that their misregulation leads to B cell-mediated diseases. cRel
and RelA are essential for generating GC B cells and plasma cells (PCs). The activation of cRel and RelA
depends on the degradation of inhibitors of NFkB (IkBs). IkBa and IkBe have different binding preferences to
cRel and RelA. IkBa binds to RelA-containing dimer (RelA:p50) with a higher affinity than cRel-containing dimer
(cRel:p50), whereas IkBe binds to cRel:p50 with a higher affinity than RelA:p50. The network of IkBa, IkBe, cRel,
and RelA is defined here as the NFkB signaling network. The role of the NFkB signaling network in generating
LLPCs versus MBCs is unknown. This project will define the role of the NFkB signaling network in the generation
of LLPCs versus MBCs. The objective of Aim 1 is to define how IkBa and IkBe regulate the generation of LLPCs
and MBCs. The objective of Aim 2 is to identify how cell surface receptors regulate cRel and RelA expression in
GC B cells, leading to the generation of LLPCs and MBCs. The objective of Aim 3 is to determine whether the
vaccine-induced response of IkBa-deficient and IkBe-deficient mice can enhance humoral immunity against
influenza infection.
The proposed research is innovative because it connects the cell signaling and transcriptional network of GC B
cells to the generation of LLPCs and MBCs and translates this mechanistic knowledge to generate long-lasting
humoral immunity against influenza viruses. This work uses newly generated cRel and RelA fluorescence
reporter mice and IkBe and IkBa knock-out mice. The combination of single-cell/bulk RNA-Seq, BCR-Seq, flow
cytometry, and intravital imaging will reveal new insights into the generation of long-lived humoral immunity that
can be applied to vaccination strategy for influenza and other infectious diseases. The proposed research is
expected to define the mechanism that allows the NFkB signaling network to regulate different gene regulatory
programs within phenotypically-identical GC B cells to generate LLPCs and MBCs, identifying a promising target
for the development of longer-lasting vaccines for influenza and other highly mutating pathogens.

Public health relevance
Project Narrative The proposed research is relevant to public health because many clinical and experimental vaccines fail to generate long-lasting humoral immunity, which is a key to preventing infection in the long term. The proposed study’s expected result is an in-depth understanding of the transcriptional regulation generating long-lasting humoral immunity that will be instrumental in identifying targets for pharmacological intervention and designing an immunomodulator/vaccine adjuvant that can enhance the duration of long-lasting humoral immunity upon vaccination. Thus, the proposed research is relevant to the NIH’s mission to develop fundamental knowledge that will help to reduce the burdens of human disease and disability.